Mechanisms of cell proliferation in whole-genome doubled cells

Unscheduled whole-genome doubling events (WGD) give rise to polyploid cells that are associated with human
disease. Most significantly, WGD generates genetically unstable tetraploid cells that can fuel tumorigenesis.
Recent computational analyses have revealed that nearly 40% of all solid tumors have undergone at least one
WGD, often early in their development, demonstrating that such events play significant roles in both the initiation
and/or progression of human malignancies. Gaining a comprehensive understanding of the mechanisms through
which whole-genome doubled cells arise and promote tumorigenesis is therefore a critical, albeit largely
unexplored area of cell biology. The goal of this proposal is to combine computational, cell biological, and animal
model methodologies to test the overarching hypothesis that whole genome-doubled cells must acquire specific
genetic adaptations that enable them to tolerate the numerous defects imparted by doubled DNA content, and
that these cells are therefore imparted with specific genetic dependencies that are not present in normal diploid
cells (i.e. ploidy-specific lethality). These hypotheses will be tested in three specific aims. Aim 1: Use an
innovative approach to rapidly quantitate the frequency and underlying cause of WGD in different tissues in vivo
and determine if this frequency is affected by aging. Aim 2: Validate KIF18A, which encodes for a mitotic kinesin,
as a ploidy-specific lethal gene in vivo, and use isogenic diploid/tetraploid cell models to perform an imaging-
based phenotypic screen to identify small molecule inhibitors of KIF18A. Aim 3: Identify genetic aberrations (e.g.
gene amplifications/deletions) that are significantly and specifically enriched in whole genome-doubled tumors,
and mechanistically define how such alterations provide ploidy-specific growth advantages in vitro and in vivo.
Successful completion of these aims will provide significant insight into the genesis, biology, and evolution of
whole-genome doubled cells, as well as potentially reveal new and innovative therapeutic avenues to selectively
kill whole-genome doubled cancer cells while sparing the normal healthy diploids from which they arose.

Public health relevance
Unscheduled whole-genome doubling events give rise to genetically unstable polyploid cells that can promote disease. The aims of this proposal are designed to identify unique the genetic adaptations acquired by polyploid cells that enable their sustained proliferation and survival. Successful completion of these aims will provide significant insight into the genesis and evolution of whole genome-doubled cells in vivo, as well as reveal innovative therapeutic avenues to selectively kill pathological polyploid cells while sparing the normal cells that comprise human tissue.